Innovating Organ Shipment by Studying Environmental Factors which Affect Organs During Cold Preservation

Abstract: There is an urgent and critical need to innovate shipment methods for human organs. While much
has been done in the last three decades to improve transplant survival rates and immunologic outcome, little
has been done to understand how to optimally care for organs during shipment. As the field of transplantation
smartly rethinks organ allocation, more work needs to be done to help improve the process of organ shipment.
In prior work, we questioned if on-demand organ shipment with unmanned aircraft, or drones, might
improve access to transplantable organs. Organ drones may decrease CIT and improve organ availability.
During initial drone experiments, novel telemetry devices showed significant differences in the pressure,
temperature, and when drone flight was compared with traditional fixed wing flight. This is particularly interesting
because recent publications have revealed differences in organ transplant outcome when organs are moved by
air versus ground. Further, it is well known that low-pressure exposure from airline flight negatively impact organ
function after trauma. There are no studies addressing these factors or their impact on transplantable organs.
We then modeled environmental factors affecting organs in a small model of heterotopic cardiac
transplant model. We found that mid-range vibration led to reduced survival when compared with non-vibrated
hearts. Explanted hearts showed increases in apoptosis and F-actin derangement. More work is needed to
determine the most appropriate way to care for organs in transit and mitigate potential risks during shipment.
This proposal builds on our expertise with innovating organ shipment. We hypothesize that CIT is
comprised of more than just time alone, and that environmental factors may impact graft survival. We will
separate pressure, temperature, and vibration to learn how each factor individually affects transplanted organs
with the greater goal of implementing strategies to mitigate each of these risks and improve organ function.
In Aim 1 we will determine, presently unmeasured, actual environmental factors that affect hearts during
transport by car, helicopter, airplane, and drone. We will calculate temperature, pressure, and vibration, and
compare telemetry findings for each shipment modality. We will then assess pre-and-post shipment biopsies for
changes cellular adhesion molecules (ICAM-1, VCAM-1) and cytoskeletal actin. In Aim 2, we will model these
forces in an animal model of heart transplant. Donor hearts will be pre-treated with pressure, temperature, or
vibration. The primary outcome measure will be graft survival. The secondary outcome measure will be non-
invasive transthoracic echocardiographic and histology for adhesion molecules and actin as in Aim 1.
Here, we will learn for the first time how the environment has been affecting thousands of human organs
during shipment. We will then learn how each component of a multi-variable cold ischemia time contributes to
organ function, immunological response, and graft survival. Together these findings will launch the field of organ
perseveration into the next decade.

Public health relevance
Project Narrative: Prompted by recent organ allocation changes requiring organs to travel more frequently, we have worked to innovate organ shipment using unmanned aircraft (i.e. drones) in the hopes of increasing organ access and decreasing cold ischemia time (CIT). Telemetry data suggested drone-shipped organs were exposed to different pressures, temperatures, and vibrations when compared with airplanes, and that different transport modes may be detrimental to organ quality. Here, we will deconstruct CIT to learn if (beyond time alone) pressure, temperature, and vibration impact organ function, with the greater goal of implementing strategies to mitigate each of these risks and improve organ outcome.